Metabolome and Microbiome Profiling in Response to Dietary Interventions in Patients with ADPKD

PROJECT SUMMARY/ABSTRACT
The applicant, Dr. Cortney Steele, completed her graduate training in clinical physiology and metabolism. Dr.
Steele's long-term goal is to develop an independent research program studying the impact of nutrition on
health outcomes in clinical populations, including kidney disease patients. Examining microbiome and
metabolome profiling in response to dietary changes and relating these indices to disease progression will
provide insightful information that may facilitate development of effective treatment strategies in the autosomal
dominant polycystic kidney disease (ADPKD) population. To help Dr. Steele meet this goal, she has initiated
postdoctoral research to investigate: 1) how the gut microbiota and plasma metabolome respond to dietary
interventions in those with ADPKD; and 2) how gut microbiota and metabolomic profiles relate to disease
progression and health measures. Dr. Steele and her mentoring team have developed a comprehensive
training plan that will build upon her previous in clinical research experience, while expanding her knowledge of
PKD, nutritional interventions, and obesity. Dr. Steele’ s primary training objectives include: 1) improve her
knowledge related to nephrology, nutrition/metabolism, epidemiology, and biostatistics; 2) advance new
technical research skills and collaborations; 3) advance experience in conducting intervention trials, both
remote and on-site; 4) improve her professional development and research network; and 5) expand science
communication skills, publication record, and grantsmanship. To achieve these goals, Dr. Steele’s proposed
research project will: 1.A) characterize longitudinal changes in the gut microbiota and plasma metabolome in
response to dietary interventions in two ongoing randomized control trials in patients with ADPKD and
overweight or obesity (DCR, daily caloric restriction of 34% per day from weight maintenance requirements
and TRF, time-restricted feeding restricting eating to a feeding window of 8 hrs/day), B) Evaluate the
association of plasma metabolome and gut microbiota profiles with measures of responsiveness to dietary
interventions, including % weight loss and △ in abdominal adiposity; 2) Evaluate the association of gut
microbiota and metabolomic profiles with indicators of kidney disease progression and measures of
cardiometabolic health. This research will lead to several first-author publications and provide preliminary data
to support continued mentored career development funding (i.e., K01). Data arising from this project will also
lead to more targeted approaches for continued research aimed at understanding microbiome composition and
metabolomics in the ADPKD population. Dr. Steele will also have numerous opportunities for co-authorship
within her sponsor’s research program at the University of Colorado Anschutz Medical Campus. Collectively,
these activities will provide an unprecedented opportunity to develop Dr. Steele’s research knowledge and
skills, while providing a foundation for a productive independent research career.

Public health relevance
PROJECT NARRATIVE Obesity is prevalent in those with autosomal dominant polycystic kidney disease (ADPKD, a genetic disorder characterized by progressive development and enlargement of multiple renal cysts that ultimately lead to loss of kidney function), but there is limited research related to lifestyle interventions. This study will examine 1) how the gut microbiota and plasma metabolome respond to dietary interventions in those with ADPKD; and 2) how gut microbiota and metabolomic profiles relate to disease progression and health measures. Data arising from this project will lead to more targeted approaches for continued research aimed at understanding microbiome composition and metabolomics in the ADPKD population.